UCSC Research Mentoring Internship Program: An Initiative to Increase Diversity and Inclusion in Genomics Research

Project? ?Summary The? ?UCSC? ?Diversity? ?Action? ?Plan? ?at? ?the? ?University? ?of? ?California,? ?Santa? ?Cruz? ?originated? ?in 2002? ?as? ?a? ?sub-award? ?of? ?the? ?UCSC? ?Genome? ?Browser.? ?On? ?the? ?UCSC? ?campus,? ?our? ?DAP? ?is known? ?as? ?the? ?Research? ?Mentoring? ?Internship? ?Program? ?(RMI),? ?a? ?research? ?education program? ?that? ?improves? ?equity? ?and? ?access? ?to? ?careers? ?in? ?genomic? ?science? ?by? ?increasing the? ?participation? ?of? ?underrepresented? ?minority? ?students.? ?The? ?RMI,? ?now? ?managed? ?by? ?the Genomics? ?Institute? ?Office? ?of? ?Diversity,? ?provides? ?mentored? ?research? ?training? ?and? ?financial support? ?for? ?underrepresented? ?minority? ?(URM)? ?students? ?in? ?both? ?undergraduate? ?and graduate? ?(pre-doctoral)? ?educational? ?training,? ?with? ?the? ?goal? ?of? ?preparing? ?and? ?advancing them? ?toward? ?successful? ?careers? ?in? ?genomic? ?science? ?or? ?its? ?ethical,? ?legal,? ?and? ?social implications? ?(ELSI).? ?Students? ?supported? ?by? ?the? ?RMI? ?are? ?assigned? ?to? ?a? ?faculty? ?research mentor? ?with? ?whom? ?they? ?train? ?10-20? ?hours? ?per? ?week.? ?Mentor? ?labs? ?may? ?be? ?in? ?any department? ?in? ?the? ?Division? ?of? ?Physical? ?and? ?Biological? ?Sciences? ?or? ?the? ?School? ?of Engineering,? ?provided? ?that? ?the? ?research? ?focuses? ?on? ?genomic? ?sciences? ?(e.g. computational? ?biology,? ?quantitative? ?sciences,? ?bioinformatics? ?and? ?technology development).? ?STEM? ?research? ?environments? ?may? ?be? ?wet? ?labs? ?or? ?computational? ?labs. ELSI? ?projects? ?are? ?usually? ?conducted? ?under? ?the? ?aegis? ?of? ?a? ?faculty? ?member? ?from? ?the Division? ?of? ?Social? ?Sciences,? ?and? ?commonly? ?approach? ?a? ?specific? ?aspect? ?of? ?genomics? ?in one? ?of? ?the? ?following? ?areas:? ?bioethics,? ?policy,? ?healthcare,? ?social? ?implications.? ?The? ?RMI provides? ?financial? ?support? ?in? ?the? ?form? ?of? ?scholarships? ?for? ?undergraduates? ?and? ?substantial fellowships? ?for? ?graduate? ?students.? ?In? ?addition? ?to? ?research? ?training,? ?the? ?program? ?offers academic? ?and? ?professional? ?development? ?workshops,? ?one-on-one? ?coaching,? ?and? ?career guidance.? ?The? ?program? ?exposes? ?students? ?to? ?the? ?culture? ?and? ?rigors? ?of? ?a? ?research environment? ?under? ?the? ?close? ?supervision? ?of? ?faculty? ?mentoring,? ?thus? ?enhancing preparation? ?for? ?and? ?success? ?in? ?graduate? ?school? ?and? ?beyond.? ?We? ?recruit? ?from? ?regional community? ?colleges? ?and? ?California? ?State? ?Universities? ?that? ?have? ?high? ?percentages? ?of students? ?from? ?low-income? ?and? ?underserved? ?populations.? ?To? ?ensure? ?successful persistence? ?to? ?degree? ?completion,? ?we? ?implement? ?retention? ?strategies? ?based? ?on? ?best practices? ?to? ?create? ?professional? ?support? ?and? ?programming? ?within? ?a? ?cutting-edge? ?research environment? ?that? ?provides? ?our? ?cohort? ?with? ?the? ?knowledge? ?and? ?tools? ?needed? ?to? ?advance to? ?meaningful? ?careers? ?in? ?genomics.

Public health relevance
Project Narrative The Research Mentoring Internship Program (RMI) at UC Santa Cruz offers mentored research training, financial support, and professional development to students pursuing careers in genomic science or in the analysis of the ethical, legal, and social implications of that research. The RMI improves equity and access to careers in genomic science by contributing to the number of academically talented and underrepresented minority (URM) students who successfully complete degrees in genomic science. Our efforts are valuable in terms of social justice, and the students who graduate from our programs and enter careers in genomics constitute a valuable contribution to the American workforce, bringing skill, talent, and diverse perspectives to fields of knowledge that promise to dramatically benefit human health.